Predoctoral Training in Pharmacological Sciences

DESCRIPTION (provided by applicant): This Predoctoral Training Program is designed to provide a broad education in the Pharmacological Sciences leading to the Ph.D. degree. The Pharmacological Sciences Training Program (PSTP) is based primarily in the Department of Pharmacology and Chemical Biology at the University Of Pittsburgh School Of Medicine, but includes faculty from three schools within the University and ten departments including Anesthesiology, Chemistry, Immunology, Medicine, Microbiology and Molecular Genetics, Neurobiology, Neurology, Otolaryngology, Pharmaceutical Sciences, and Structural Biology. Graduate students entering this program are typically first recruited into the Interdisciplinary Biomedical Sciences Graduate Program where they join a program that includes core didactic education in biomedical sciences, scientific ethics and statistics and research rotations. Students then transfer into the specialized Ph.D. program of their choice and become candidates for PSTP support in their second year. The training program provides graduate classes in the essential elements of modern pharmacology including neuropharmacology, cancer pharmacology, cardiovascular pharmacology, signal transduction and drug discovery and also the elements or quantitative pharmacokinetics, pharmacodynamics and drug metabolism. Students choose mentors from a well-funded faculty in one of six research areas: Cancer Pharmacology, Cell and Organ System Pharmacology, Drug Discovery, Neuropharmacology. Signal Transduction and Structural Pharmacology. Following completion of the comprehensive exam and a dissertation proposal, students are engaged full time in research in the third and subsequent years of this program. The PSTP also emphasizes training in the responsible conduct of research and provides training in skills (e.g. public presentations) that promote professional development. The PSTP thus provides a contemporary and exciting training opportunity for motivated students within a rich research environment and aims to generate Ph.D. graduates with a broad understanding of the discipline of pharmacology. RELEVANCE (See instructions): Students that participate in this program will receive training in fundamental areas of pharmacology and physiology as well as participate in state of the art research that examines the mechanisms of action of many drugs that are either currently in use or being developed to treat a variety of human diseases. The knowledge gained by these trainees will directly impact human health as they seek to apply this knowledge as either basic researchers, clinicians, educators, business leaders or public policy advocates towards the development of safe and effective drugs.